Coordinating Center for Community-Based Interventions with Vulnerable Populations

ABSTRACT
The goal of the Centers for Disease Control and Prevention (CDC) is to identify and implement
innovative strategies to improve access to eye care to detect and manage glaucoma and other eye
diseases in high-risk populations. The CDC will fund up to three Component A awardees to study
these innovative strategies in community-based settings for replication and scaling in the United
States.
The Coordinating Center for Community-Based Interventions with Vulnerable Populations
(Component B) will play a critical role in facilitating collaborations between Component A awardees
and serve as an administrative hub, accelerating the development of the common evaluation protocol,
supporting communication among awardees, and providing the web-based infrastructure for
information exchange. Over time, the Coordinating Center will help maximize the value of the
strategies of Component A awardees by contributing to the dissemination and translation of research
findings.
The Coordinating Center will provide a strong organizational foundation and accommodate the needs
of the awardees. Specific aims of the Coordinating Center include: (1) collaborate with Component A
awardees to develop a common evaluation protocol; (2) provide support for governance, meetings,
and administrative functions; and (3) establish the infrastructure and develop tools and processes to
support communication and information exchange.

Public health relevance
PROJECT NARRATIVE Columbia University in partnership with Westat proposes to serve as the Coordinating Center for Community-Based Interventions with Vulnerable Populations. The Coordinating Center will support Component A awardees who will independently implement and study the community- based interventions. By serving as the administrative hub, the Coordinating Center will facilitate the development of a common evaluation protocol, coordinate the process to support communication, provide the web-based infrastructure for information exchange, and assist with the dissemination and translation of research findings.